Simulation of Multi-Protein systems

The main area of research, supported by the grant R01 GM118078, entitled “Simulation of Multi-Protein
Systems”, is investigating the interactions between proteins in cellular assemblies. Elucidating such
interactions will further mechanistic understanding of cellular processes, and will enable effective
therapy development. NIGMS administrative supplement is requested to acquire a high performance
GPU cluster to develop physics aware deep learning models . Typically atomic simulations are
performed using either physics or machine learning based approaches, with results obtained by the two
methods being orthogonal to each other. Instead of a trivial combination of methods, the project goal is
to develop special deep neural network architectures, which encode geometry and physics of the
underlying system. The inference of such network will be performing realistic physical simulations, with
parameters trained on the available data to optimally reproduce experimental observations. Training of
such models require significant GPU resources thus justifying the need for the cluster. The new models
will be applied to understanding the molecular mechanisms in healthy and diseased cells on the
genomics scale. In addition, the results of the research in the Kozakov lab are made available
through the macromolecular modeling server ClusPro, a public resource with more than 25000 users
running tens of thousands calculation each month. Deploying these methods on the server is also
requiring significant GPU resources. Thus the purchased GPU cluster will serve dual goals, first provide
training time to develop and apply the new models and then adding to the ClusPro backend.

Public health relevance
The goal of the supplement is to use purchase GPU cluster to develop deep learning methods whose inference simulate physical processes of molecular association, apply the models to understand the mechanisms of disease in collaboration with experimentalists, and deploy them through public servers for community access.